Impacts of Borrelia burgdorferi Gac protein on infectivity and regulation of virulence protein expression

ABSTRACT
We recently found that the Gac DNA-binding protein of Borrelia burgdorferi, the Lyme disease bacterium,
functions as a transcriptional repressor of the essential ospC gene. RNA-sequencing (RNA-Seq) analyses of a
gac mutant revealed that Gac impacts levels of transcripts of several other virulence-associated proteins,
including the alternative sigma factors RpoN and RpoS. Prior studies demonstrated that RpoN is required for
expression of RpoS, and both are required for mammalian infection. The planned studies will further
investigate the functions of Gac in the Lyme disease spirochete, including its impacts on mammalian and tick
infection and molecular characterization of Gac's impacts on rpoN expression. Results of these studies will
provide important insights on regulatory mechanisms that control virulence of the Lyme disease spirochete and
help identify key components for development of improved, specific antibacterials.

Public health relevance
NARRATIVE The Lyme disease spirochete, Borrelia burgdorferi, produces a unique DNA-binding protein named Gac. Our biochemical and genetic analyses indicate that Gac regulates expression of several genes that encode proteins that are essential for mammalian infection, including the alternative sigma factors RpoN and RpoS. Our studies will define the role of Gac during B. burgdorferi infection processes, and assess the mechanism by which Gac controls transcription of RpoN.